A2CPS Administrative Core

ADMINISTRATIVE CORE
SUMMARY
The ODGC Administrative Core (ODGC) will be responsible for promoting the overall goals of the A2CPS
Program by supervising, coordinating, and facilitating all ODGC activities. The ODGC Administrative Core team
will be organized into three groups: Leadership, which will be comprised of the four ODGC multi-PIs; Domain
Experts with expertise in the clinical, psychosocial, physiological and genetic aspects of pain, translational
research on therapies for chronic pain, and neuroimaging; and Administrative Staff. The Leadership team has
strong scientific and project leadership experience: the Project Lead has a background in computational biology,
population genetics and genomics, and is the Director of the Center for Computational Biology and Bioinformatics
at her institution; the Co-Lead is a physician-scientist with expertise in extracellular RNA and stem cell biology
and genomics who served as Co-Chair of the Steering Committee for a NIH Common Fund Consortium; one
Co-I is the Director of the Genomics Center at her institution, which provides genomics training, consultation,
and services to over 200 laboratories; the other Co-I is Director of the Institute for Genomic Medicine and Director
of the Bio-Computational Center of the CTSA at her institution with a research focus on understanding genetic
predisposition to complex diseases. The primary tasks of the Administrative Core are organized into two Aims.
Aim 1, which concentrates on intra-ODGC management, will encompass establishment of infrastructure for
coordinating intra-ODGC standing and ad hoc meetings and conference calls, setting goals, monitoring progress,
allocating resources, facilitating resolution of technical challenges, promoting scientific exchange among ODGC
investigators, resolving disputes, engaging consultants, preparing NIH progress reports, maintaining regulatory
compliance, and planning and coordinating abstract and manuscript preparation. Aim 2 is focused on
coordinating interactions between the ODGC and other elements of the A2CPS, including the other Program
Centers, the External Program Consultants, and NIH Program Staff. These interactions will include discussions
leading to: determination of the definitive set of omic assays that will be included in the Program; selection of the
40 primary outcome candidate biomarkers; establishment of Standard Operating Procedures for biospecimen
collection, processing and storage; and development of systems for sample and data tracking, recording of
relevant metadata, and transferring data and metadata from the ODGC to the DIRC. The ODGC Administrative
Core will also establish intellectual property agreements, including those associated with materials and data
transfer among ODGC Cores/Components and other A2CPS Centers, and organize travel and hotel
accommodation of ODGC personnel for the A2CPS Program in-person meetings. The Adminstrative Core
organizational structure will be designed to provide the leadership, project and data management, and
administrative support that will contribute to the success of the ODGC and the A2CPS Program as a whole.